Assessment of reproductive outcomes on adult offspring from in vitro fertilization using a mouse model

Project Abstract
Assisted Reproductive Technologies (ART) are non-coital methods of conception that are used to treat
infertility and achieve a pregnancy. As many as 9 million births worldwide have resulted from ART. In the
coming years, it is expected that the number of births by ART will increase as more couples postpone having
children or infertility arises on a more regular basis. Procedures used in ART include complex techniques such
as in vitro fertilization (IVF) and intracytoplasmic sperm injection, and as well as less complex procedures such
as gamete and embryo cryopreservation and preimplantation genetic testing. Recently, work from various
laboratories has shown that ART is associated with health risks for mothers and fetuses such as stillbirth,
preterm birth, intrauterine growth restriction, abnormal placentation, and other pregnancy complications. Also,
more recent studies have shown that IVF offspring can develop metabolic and/or cardiovascular outcomes
during adulthood. Mouse models support these clinical observations and have shown that adult IVF offspring
can develop metabolic and cardiovascular outcomes. Technologies used in assisted reproduction are
continuously refined to increase pregnancy success, but the effects of newer techniques have not been
assessed prior to implementation. Because the reproductive system has been shown to be sensitive to
perturbations during intrauterine development potentially impacting future functions, the main object of this
proposal is to study how IVF procedures affect normal function of reproductive system in IVF offspring in mice
and elucidate underlying genetic and epigenetic mechanisms involved in observed outcomes. Because
females and males have unique pathways and physiological functions their reproductive systems cannot be
analyzed together, for this reason aim 1 of this proposal will address changes in morphology, cell composition,
transcriptome, histone posttranslational modifications and fertility in gonads and gametes from adult female
offspring, while aim 2 will address similar endpoints in males. Identifying possible alterations in IVF offspring in
the reproductive system is important (1) because any procedure use to help achieve a pregnancy should
ensure a healthy child which will not develop future complications and (2) because IVF is commonly used by
infertile couples the underlying infertility conditions could passed to the offspring ultimately rendering the
offspring dependent of IVF. The plan proposed in this fellowship will prove to be useful for future studies of
complex tissues and also for identifying mechanisms influenced by IVF that could be interrogated in the future
to minimize adverse effects in offspring.

Public health relevance
Project Narrative Assisted Reproductive Technologies have helped many couples worldwide to conceive children. However, adverse metabolic and cardiovascular outcomes have been observed, which are associated with ART procedures. Using our advanced model for IVF, this proposal will study reproductive outcomes in offspring induced by ART and the underlying sex specific mechanisms involved. Considering that healthy offspring is one of the main goals of ART, it is critical that these offspring are not wholly dependent upon ART.